GLUTAMATE TRANSMISSION AND AMPHETAMINE SENSITIZATION

DESCRIPTION (Verbatim from the Applicant's Abstract): Our working hypothesis is that drug addiction is a maladaptive form of glutamate-dependent plasticity. Our prior work has used behavioral sensitization as an animal model for intensification of drug craving. We have shown that glutamate transmission is required for the development of sensitization and that glutamate systems are dramatically altered in sensitized rats. This proposal will further characterize mechanisms underlying changes in glutamate transmission produced by amphetamine or by drug-associated environmental cues. Each of the aims focuses on a different aspect of glutamate's role in sensitization. Aim 1 is based on the hypothesis that the induction of sensitization requires potentiation of AMPA transmission within the ventral tegmental area (VTA). We propose to determine if this is mediated by Narp, a secreted immediate early gene product that clusters AMPA receptors at synaptic sites. Preliminary data show that Narp is elevated in VTA after both acute and repeated amphetamine treatment. Experiments will characterize Narp distribution in VTA, further examine the effects of amphetamine on its expression, and determine if the development of sensitization is prevented by chronic intra-VTA infusion of antisense oligodeoxynucleotides to Narp. Aim 2 builds on prior studies showing that repeated amphetamine decreases GluR1, GluR2 and NR1 levels in the nucleus accumbens (NAc), leading to changes in neuronal excitability that are hypothesized to mediate the long-term maintenance of sensitization. We will compare the persistence of these changes to that of behavioral sensitization, identify cell types within NAc that exhibit altered subunit expression, and examine amphetamine's possible effects on NR2 subunits and NR1 slice variants. Aim 3 will extend our studies of drug-induced plasticity to conditioned locomotion, a phenomenon that may provide insight into situational drug craving. We hypothesize that expression of conditioned locomotion requires increased activity of glutamate projections from prefrontal and cingulate cortices, or amygdala to the NAc. We will determine if the expression of conditioned locomotion is prevented by reversibly inactivating these regions with lidocaine or by blocking AMPA transmission. Microdialysis studies will directly examine the possibility that drug-associated cues activate glutamate transmission. Finally, we will determine if pharmacological treatments that reverse established locomotor sensitization also reverse conditioned locomotion.